Zfp423 Mechanisms in Joubert Syndrome and Related Disorders

Project Summary: This project focuses on cellular, genetic, and molecular mechanisms that underlie developmental abnormalities in ZNF423-realted ciliopathy. The ciliopathies comprise a spectrum of disorders unified by defects in primary cilia. Clinical presentations range from primary involvement of a single organ (most often hindbrain, kidney, liver or eye) to more severe presentations, such as Meckel syndrome, with severe and pleiotropic developmental phenotypes in several organs. Several genes have been identified for ciliopathy disorders, with the overwhelming majority encoding physical components of primary cilia. Regulatory genes that control cilium-dependent signaling and genetic modifiers that control the outcome of ciliary defects are only beginning to be tied to pathogenic mechanisms. This project focuses on the role and mechanisms of ZNF423, a constitutively nuclear transcriptional regulatory protein mutated in Joubert syndrome (JBTS19) and nephronophthisis (NPHP14) patients. ZNF423 is thought to comprise an integrative node among several transcriptional complexes that respond to classical developmental signals. As ZNF423 expression is also developmentally dynamic, the extent to which phenotypes are cell autonomous, rather than defects in reciprocal intercellular signaling, remains unclear. Aim 1 will use recently developed genetic tools (MADM) to assess cell autonomy by creating a simple platform for inducing and marking mitotic clones in situ. Because patient mutations are individually rare, often found on only one allele, and found in subjects with a range of presentations, it remains unclear what fraction of patients is attributable to ZNF423 and which ZNF423 mutations are truly pathogenic. Aim 2 will use genome editing in a sensitive and well-validated mouse model to test phenotypic effect of patient-derived mutations. It remains unclear whether specific targets of ZNF423 activity might be able to modulate phenotype. Aim 3 will determine whether decreasing activity of newly identified ZNF423-repressed genes, whose expression is increased in both knockdown cell and mutant animals, can improve cilium-dependent functions and emergent phenotypes in the Zfp423 mouse model.

Public health relevance
Project Narrative: Ciliopathies are a large group of individually rare genetic disorders affecting several organs that have in common defects in genes encoding components of the primary cilium, a small organelle important for intercellular signaling. Individual disorders may be caused by more than one gene and single genes often contribute to more than one of these disorders. This application applies genetic and molecular tools to test mechanistic models for how defects in a gene for a nuclear regulatory protein, ZNF423, result in characteristic phenotypes of a ciliopathy disorder.